Chemistry: Analytical Track 3: Animal Food Testing

SUMMARY: CHEMISTRY ANALYTICAL TRACK 3 (ANIMAL FOOD TESTING) Household safety can be threatened by pet food that is adulterated with a wide range of chemicals, or by contaminated animal feed that forms the start of the nation’s food chain. The core tenet of this large and multifaceted proposal is to contribute a comprehensive and integrated food protection laboratory hub to the Food Emergency Response Network (FERN) that is capable of analyzing many different foods across a diversity of threat priorities. Surveilling animal/pet food for chemical contamination addresses a potential vulnerability, and is thus an integral component of our goal of ensuring a safe food supply. This proposal seeks to maintain and extend the MDH Laboratories Administration’s capability by testing diverse animal foods (100 samples annually) using ISO/IEC 17025:2017-accredited methods, extensive technical capabilities, and the experienced Analysts of the Food Chemistry Laboratory. The Laboratory proposes to test 100 samples annually from the commodity/hazard pair that the FDA has determined to be national priorities. This planned strategy complements the Laboratory’s high-volume human food testing activities.